University of Wisconsin Prostate SPORE

PROJECT SUMMARY
The University of Wisconsin (UW) Prostate Cancer SPORE is a highly collaborative research proposal that links
basic scientists with prostate cancer clinicians to advance treatment strategies for prostate cancer patients. The
broad objectives of this SPORE are to: 1) Increase multidisciplinary translational research and develop the next
generation of prostate cancer researchers, 2) Develop common resources to promote advances, 3) Translate
promising new approaches into patients, and 4) Improve overall survival and quality of life for patients with
prostate cancer. A crosscutting theme that encompasses this SPORE is understanding tumor resistance in
advanced prostate cancer and exploiting this knowledge to improve patient outcomes. The UW Prostate Cancer
SPORE has three primary research projects: 1) Tumor Microenvironment Initiators of the Metastatic Cascade in
High-Risk Prostate Cancer, 2) Androgen Deprivation as an Immune Modulating Therapy in Combination with
Targeted Immunotherapy of Prostate Cancer, and 3) Extending Clinical Benefit by Selective Treatment of
Resistant Lesions in mCRPC. The SPORE will support this research with three Cores (Administrative, Integrated
Pathology Radiology, and Biostatistics and Bioinformatics). The Career Enhancement Program and
Developmental Research Program will engage new and established investigators and further translational goals
in a rich multidisciplinary environment. When completed, the research of the UW Prostate Cancer SPORE will
advance our treatments and understanding of prostate cancer and undoubtedly beneficially impact patients with
this disease.

Public health relevance
NARRATIVE Prostate cancer is the most common cancer in men and a source of significant morbidity and mortality (>30,000 deaths annually). This project will combine our cutting-edge basic science discoveries with clinical (surgical, medical and radiation oncologists) expertise to exploit novel observations that will improve outcomes and quality of life for patients with this disease. Using state-of-the-art imaging, bioinformatics and novel pathology resources we will develop new and exploit new diagnostic approaches and treatments that will change the way prostate cancer is managed.